Gaining a clear view of HIV cell-cell spread using APEX proximity labeling

Project Abstract
This project aims to better understand the molecular mechanisms of HIV spread through cell-cell contact
across a virological synapse (VS), a specialized structure formed between HIV infected cells and target cells.
We have developed a novel flow cytometry assay for quantifying and purifying infected cell-target cell pairs.
We have generated infected producer cells that stably express ascorbate peroxidase (APEX) enzymes
localized to different subcellular compartments. Upon addition of hydrogen peroxide and biotin-phenol, APEX
generates short-lived BP radicals that covalently biotinylate proteins and RNAs within a few nanometers of the
enzyme. We will use APEX localized to nucleus, cytoplasm, ER, plasma membrane, and mitochrondria to
provide a robust analysis of how host and viral proteins and RNAs are regulated by VS formation. The
successful completion of this grant will identify determinants of the VS formation and its composition, identify
changes to host cell proteins following VS formation with an emphasis on RNA binding proteins, and determine
how host and viral RNAs are regulated by cell-cell contact.
Aim 1: Identify determinants and composition of virological synapse (VS) formation.
Aim 2: Determine how VS formation affects protein abundance and localization within infected cells, with an
emphasis on cellular RNA binding proteins.
Aim 3: Determine how cell-cell signaling during VS formation impacts the RNA regulatory landscape of
infected cells.

Public health relevance
Project Narrative This project seeks to better understand how HIV-1 spreads through cell-cell contact, an important route of viral infection. We have developed an innovative flow cytometry assay for quantifying and purifying infected cell- target cell pairs, which we will use to define determinants of VS formation and to purify interacting cells for powerful proteomic and transcriptomic analysis using ascorbate peroxidase (APEX) proximity labeling to quantify how host and viral proteins change in location over time following cell-cell contact. We will also examine the effect of cell-cell contact on transcription of the HIV provirus and regulation of viral RNAs, providing unprecedented detail into cell-cell spread of HIV that could lead to novel therapies to disrupt this important pathway.